DST/CSA IN NONHLA IDENTICAL LIVE DONOR TXP/CADAVER RENAL ALLOGRAFT/BONE MARROW

Cooperative Clinical Trials in Transpantation is a multi-center trial funded by an NIH grant with two protocols currently having IRB approval, "Pre- and Posttransplant Donor Specific Transfusion/Cyclosporine A in Non- HLA Identical Living Related Kidney Transplant Recipients" and "Cadaver Renal Allograft and Bone Marrow Transfusion". The purpose of these studies includes assessing the effectiveness of a donor specific transfusion/Cyclosporine A protocol to induce donor specific unresponsiveness in recipients of kidneys from one or zero haplotype matched donors and determining the safety and benefit in terms of lessened rejection and graft survival from the administration of donor bone marow cells to recipients of cadaveric renal transplants. One of the measures of graft function is GFR. For this protocol, measurement is obtained at 3, 12 and 24 months using Iohexol. This outpatient procedure involves injection of the Iohexol followed by blood sampling at 2, 3, and 4 hours post Iohexol injection. The samples are then mailed to the central lab in Minnesota. This particular measurement of GFR is not routinely used at UAB, but Iohexol administration and blood sampling could be done at the GCRC.